Yearly Workshop in the Event-Related Potential Technique

The purpose of this project is to continue supporting a highly successful ten-day intensive summer training
workshop focusing on EEG and ERP methods. These methods are widely used to measure the time course of
brain activity across a range of basic science and clinical science domains. The workshop is intended for
beginning and intermediate EEG/ERP researchers, and it will provide them with training in the essential
aspects of EEG/ERP methodology, giving them a solid foundation for conducting innovative research on typical
and disordered functioning of the mind and brain.
The project directors are well-established researchers with experience addressing both basic science and
clinical science questions with EEG and ERPs. The workshops will alternate between Davis and San Diego,
which contain large and vibrant communities of EEG/ERP researchers. In addition to the project directors, 21
well-established EEG/ERP researchers from the Davis and San Diego regions and 2 visiting EEG/ERP experts
will serve as the faculty for the yearly workshops.
The workshop participants will come from a variety of disciplines, including cognitive science, cognitive
neuroscience, clinical psychology, experimental psychopathology, neurology, psychiatry, developmental
psychology, and gerontology. This multi-disciplinary group of participants reflects the broad use of EEG/ERPs
across the many domains that focus on neural and mental functioning. The participants will also represent a
variety of career stages, including graduate and medical students, postdocs, residents, and junior faculty.
The workshop will involve a combination of lectures, data analysis activities, discussions, and breakout
sessions. An integrated set of lectures on the fundamentals of EEG/ERP methodology will be given by the
project directors. These lectures will accompanied by hands-on data analysis activities. Lectures on special
topics, including advanced techniques and applications to clinical populations, will be given by the other
faculty. Several small-group discussions and breakout sessions will also be included, led by the workshop
faculty, that will focus on advanced methods and on critical evaluation of published research.
Significant outreach and dissemination efforts will spread the educational benefits of this workshop to a
broader group of researchers. These efforts are based on a web site, http://erpinfo.org, which provides lecture
notes, information about methods, data analysis software, and sample datasets to the worldwide research
community. We will also use social media to disseminate information about EEG/ERP methodology to a broad
audience of researchers. Thus, the impact of this project will go far beyond the workshop participants.
The ultimate goal of this project is to increase the quality and quantity of future EEG/ERP research so that
this valuable technique can have a greater impact on scientific progress in the many basic science and clinical
disciplines that focus on the human mind and brain.

Public health relevance
Disorders of mind and brain are prevalent, can be personally devastating, and lead to a substantial economic burden. The electroencephalogram (EEG) and event-related potential (ERP) techniques provide powerful methods for understanding these disorders, beginning with basic science research on typical brain function and ending with biomarkers that are used in discovering and testing new treatments. The proposed workshop seeks to enhance the ability of basic and clinical scientists to use these powerful techniques, thereby increasing the rate of scientific discovery and treatment development.